SEER-LINKED PEDIATRIC CANCER WHOLE SLIDE IMAGING PILOT - UNIVERSITY OF HAWAII HHSN261201800011I POP 8/20/2020-8/19/2021

Project Abstract: The HTR has all of the necessary services, qualified personnel, material, equipment, and facilities to participate in this pilot project to determine the feasibility of obtaining WSIs and associated metadata.